Healthy People 2030

Project Summary
The key objectives of the Healthy People 2030 Scientific Meetings are to:
1. Reduce infections caused by E. coli STEC, Salmonella, Campylobacter, Listeria; and the number
of Norovirus outbreaks.
2. Develop and implement a plan to achieve these and other Healthy People 2030 Objectives.
AFDO proposes the 2030 Healthy People Scientific Meeting plan to follow this format:
 Years 2022, 2024, and 2026 will be large scale meetings inviting all participating workgroup
members and other Subject Matter Experts (SME) as needed.
 Years 2023 and 2025 will be specific workgroup events inviting only those experts who are needed
to further the progress of the workgroup objectives.
During these meetings a group of 130+ Food Safety Leaders will come together to discuss changes needed
to reduce foodborne illness. Targeted action plans will be refined in the Healthy People 2030 categories:
E. coli STEC, Listeria, Salmonella, Campylobacter and norovirus and various commodities.
Following this meeting AFDO will continue to lead the establishment of an AFDO Healthy People 2030
Steering Committee comprised of food safety leaders in government, associations and consumer groups
to help guide the next steps. The workgroups have been formed in the following three areas:
 Salmonella in Poultry.
 Norovirus Reduction through Retail Activities.
 Produce and E. coli O157:H7.
Each workgroup reports their activities to the steering committee. If the activities laid out by the working
groups are achieved a notable reduction in infections from the above pathogens will be the outcome. The
advancement of scientific knowledge will be achieved through the completion of the charges of each
workgroup.

Public health relevance
Project Narrative The relevance of the Health People 2030 Scientific Meetings to public health is the reduction of infections caused by E. coli STEC, Salmonella, Campylobacter, Listeria; and the number of Norovirus outbreaks.